FINANCIAL STATUS--RETIREMENT SAVING PROGRAMS

The general goals of the analysis are first, to further our understanding of the effects of special retirement saving programs on saving for retirement, and second, to determine the extent to which uncertainty about future income effects the financial well- being of the elderly. The specific aims of the research proposed here are: 1. To use the most recent data available to extend our previous analyses of the net saving effect of individual retirement accounts. 2. To estimate the saving effect of Keogh and 4Olk plans. 3. To assess the potential effect of these recent programs on the future financial status of retirees.